South Carolina Cancer Disparities Research Center (SC CADRE)

SUMMARY
This five-year U54 proposal is a collaborative, inter-institutional partnership between South Carolina State
University (SCSU), an Historically Black University (HBCU), and the Medical University of South Carolina
Hollings Cancer Center (MUSC-HCC), a National Cancer Institute-designated cancer center. The partnership
began in 2011 under the auspices of an NCI P20 CPACHE grant and has grown to produce this U54 South
Carolina Cancer Disparities Research Center (SC CADRE) application. With input from their joint community
partner, the Regional Medical Center of Orangeburg Mabry Cancer Center (RMC-MCC), investigators at both
institutions collaborated to design the SC CADRE. The overarching goals of the SC CADRE are to increase
SCSU's capacity to conduct transdisciplinary cancer research and to further strengthen and extend a
longitudinal research education pipeline that will catalyze a new diverse generation of biomedical researchers
focused on cancer disparities. The SC CADRE has three major themes. The first focuses on evaluating the
relationship between obesity and prostate and breast cancer disparities. The second theme emphasizes
evaluation of advanced glycation endproducts (AGEs) as a novel biomarker related to cancer, cancer
disparities, and obesity. The third theme highlights the inclusion of a population unique to the US southeastern
coastal region, the Sea Island (SI)/Gullah population. Within five years, the SC CADRE aims for: 1) further
elucidation of molecular mechanisms contributing to cancer disparities; 2) an enhanced pipeline of diverse
cancer researchers; 3) an increased number of NIH research proposals led by SCSU faculty as independent
investigators; and 4) greater community engagement in cancer research. Due to the longstanding SCSU
/MUSC-HCC academic partnership and each entity's research and educational strengths and community
relationships, the SC CADRE is poised to transform cancer health outcomes for South Carolinians.

Public health relevance
OVERALL PROJECT NARRATIVE The South Carolina Cancer Disparities Research Center is an inter-institutional partnership between South Carolina State University (SCSU) and the Medical University of South Carolina Hollings Cancer Center. Incorporating community engagement, these two institutions will build a lasting, sustainable, translational cancer research structure at SCSU and further strengthen a research education pipeline that will catalyze a new diverse generation of cancer researchers.